The Role of Cyclooxygenase-2 in Podocyte Injury in Diabetic Nephropathy

DESCRIPTION (provided by applicant): Project Summary/Abstract The podocyte is the primary glomerular cell targeted for injury during the development and progression of glomerular diseases that eventuate in end stage renal disease (ESRD). Renal expression of cyclooxygenase-2 (COX-2) increases in models of progressive renal injury, and selective COX-2 inhibitors decrease proteinuria and retard progressive renal injury in models of renal ablation, diabetes and salt- sensitive hypertension. However, the mechanisms by which inhibition of prostaglandin synthesis can ameliorate progressive renal injury remain undetermined. We propose that local expression of COX-2 in podocytes predisposes to progressive glomerular injury. We and others have demonstrated a selective increase of COX-2 expression in podocytes in models of progressive glomerular injury and found that over- expression of COX-2 in podocytes renders the glomerulus susceptible to adriamycin nephropathy. However, the mechanisms underlying COX-2 up-regulation in podocytes and potential roles in podocyte function in response to injury remain incompletely understood. We hypothesize increased podocyte COX-2 generates metabolites that interact with the local podocyte RAS, predisposing the podocyte to further injury in response to renal insults. The goal of these studies is to examine the potential role of prostaglandins as mediators and/or modulators of podocyte injury during the development of diabetic nephropathy. We propose two complementary specific aims. In Specific Aim I, we will investigate the role of altered COX-2 expression in podocyte injury during diabetic nephropathy in vivo, using genetically engineered mice that either selectively overexpress COX-2 or have genetic deletion of COX-2 in podocytes. We will also utilize mice with genetic deletions of specific prostanoid receptors to determine which prostaglandin(s) mediate podocyte injury and will elucidate interactions between podocyte COX-2 and the local podocyte renin-angiotensin system (RAS) during the development of diabetic nephropathy. In Specific Aim II, we will investigate the mechanisms by which COX-2 increases podocyte injury in response to high glucose in vitro using conditionally immortalized mouse podocytes from wild type mice, from the transgenic mice overexpressing COX-2 or null for COX-2 expression in podocytes. We will investigate the effects of high glucose on 1) the signals leading to increased podocyte COX-2 expression;2) the effects of alterations in COX-2 expression on structure and function of differentiated podocytes in response to high glucose;and 3) the role of podocyte COX-2 as a mediator of increased production of ROS in podocytes. Although COX-2 inhibitors effectively ameliorate renal injury in animal models, the awareness of their potential to promote thrombotic vascular injury and to raise blood pressure preclude their clinical use in patients with progressive renal disease. Identification of which prostaglandins mediate glomerular injury and the determination of their mechanisms of injury may allow the development of therapeutic strategies with fewer potential side effects. PUBLIC HEALTH RELEVANCE: Project Narrative Over 20 million people in the United States have diabetes. Of these individuals, as many as one-third may develop diabetic nephropathy, the natural course of which can result in end stage renal disease (ESRD), as well as conferring markedly increased cardiovascular risks. Diabetes mellitus accounts for over 40% of percent of all new cases of ESRD making it the number one single disease requiring dialysis or transplantation in the United States. The economic burden of diabetes-related ESRD to U.S. medical care is estimated to be over $16 billion per year. The Veteran population is also at increased risk and the prevalence of diabetic nephropathy has skyrocketed it this population, with over 12% of the Veteran population served by the VA medical system now experiencing diabetes. The clinical syndrome of diabetic nephropathy (DN) is comprised of albuminuria, characteristic renal histopathologic changes and decreased renal function. Recent studies have identified the glomerular podocyte as both initiator and target of diabetic nephropathy. Our recent unpublished studies have suggested that prostaglandins derived from cyclooxygenase-2 (COX-2) expressed in the podocyte may be mediators of progressive podocyte injury in diabetic nephropathy. The current studies are designed to identify the prostaglandin(s) involved and elucidate mechanisms of injury. It is hoped that such studies may lead to targeted therapeutic options with a favorable risk-benefit profile that can prevent or slow the development of diabetic nephropathy.

Public health relevance
Project Narrative Over 20 million people in the United States have diabetes. Of these individuals, as many as one-third may develop diabetic nephropathy, the natural course of which can result in end stage renal disease (ESRD), as well as conferring markedly increased cardiovascular risks. Diabetes mellitus accounts for over 40% of percent of all new cases of ESRD making it the number one single disease requiring dialysis or transplantation in the United States. The economic burden of diabetes-related ESRD to U.S. medical care is estimated to be over $16 billion per year. The Veteran population is also at increased risk and the prevalence of diabetic nephropathy has skyrocketed it this population, with over 12% of the Veteran population served by the VA medical system now experiencing diabetes. The clinical syndrome of diabetic nephropathy (DN) is comprised of albuminuria, characteristic renal histopathologic changes and decreased renal function. Recent studies have identified the glomerular podocyte as both initiator and target of diabetic nephropathy. Our recent unpublished studies have suggested that prostaglandins derived from cyclooxygenase-2 (COX-2) expressed in the podocyte may be mediators of progressive podocyte injury in diabetic nephropathy. The current studies are designed to identify the prostaglandin(s) involved and elucidate mechanisms of injury. It is hoped that such studies may lead to targeted therapeutic options with a favorable risk-benefit profile that can prevent or slow the development of diabetic nephropathy.